TO4R: STATISTICAL PROGRAMMING AND ANALYSIS

The purpose of this Task Order is to combine all data processing, management, and analytic activities related to Epidemiology Branch studies into one budget. Personnel from both the Contractor and Subcontractor will conduct data analysis. Application development and data analysis activities also fall under this area when not specific to a single Task Order.